Development of Software to Rapidly Assess Placenta Images at Birth

Development of Software to Rapidly Assess Placenta Images at Birth
Project Summary
The placenta is a window into the events of pregnancy and the health of the mother and baby, yet only about
20% of placentas in the US are assessed by pathology exams and placental data is often neglected in
pregnancy research. Since both the mother and fetus contribute to and modulate placental development and
function, data from placental examination may inform short- and long-term clinical care of both mother and
child. Placental pathology remains under-used due to the time, cost, expertise, and facilities needed, even in
high-resource settings. Placental assessment can and should be more accessible to pathologists, clinicians,
and researchers, and assessment at birth can more readily aid clinical decisions and relate findings to
patients. Prior work has used photographic images to measure characteristics such as shape and cord coiling
and related these characteristics to placental diagnoses and outcomes of clinical importance. This project
aims to leverage the simplicity and low cost of digital photographs and the computational and decision
power of recent advances in artificial intelligence (AI) to create software for comprehensive placental
assessment from images of gross placentas. The software could address the need for widespread, simple
placenta assessment, particularly when information is needed urgently, pathologists are not highly trained for
placental pathology, or where resources only allow a small fraction of placentas to be reviewed. The
investigative team, with extensive expertise in placental pathology and research, clinical care, medical
informatics/AI, and image understanding, has developed an initial prototype with promising results for
predicting several clinically impactful diagnoses. Our preliminary data demonstrates that extensive data can
be collected from placental photos and that computational techniques allow the connection of abstracted data
to identify placental disease. The goal of this proposal is to develop and validate software to assess
placentas from digital photographs in any delivery setting. An extensive, first-of-its-kind dataset will be
created from three large hospitals including images and expert pathology reports from pregnancies with
abnormal and healthy outcomes (n>50,000). These sites include a range of characteristics across income,
race/ethnicity, health risks, and hospital resources. The resulting software will glean visual characteristics
from the disc, cord, and membranes and accurately identify specific features (e.g., shape) and diagnoses
(e.g., chorioamnionitis). The immediate information could impact clinical care before hospital discharge, and
ease-of-use will allow inclusion in pregnancy research. This software has the ability to strengthen traditional
pathology exams by standardizing and enhancing the data collected, providing better information to
pathologists. With such huge advances in technology, placental assessment at birth can no longer be viewed
as nonessential or too difficult. When fully developed and validated clinically in a range of birth settings, this
software could have the power to impact the care of millions of mothers and children around the world.

Public health relevance
Project Narrative This research has enormous potential to impact public health by providing a simple, low-cost tool for assessing placentas and incorporating diagnoses into clinical care in the highly sensitive time for mother and newborn immediately following birth. Broad implementation of this software could contribute to improved knowledge of the placenta and better maternal/child health outcomes, as well as connecting more clinicians to the use of important placental diagnoses.